Developing Population-Generalizable Deep Learning Models for Automated Glaucoma Screening

Project Summary
Motivation: Glaucoma is a leading cause of irreversible blindness affecting 3 million patients in the US. About
50% of people with glaucoma are unaware of their condition, particularly due to a lack of access to routine
ophthalmic care. Glaucoma detection with deep learning using retinal imaging is promising to provide cost-effective mass glaucoma screening, which can be deployed in primary care and pharmacies without needing
individuals to visit more expensive eye clinics for screening. It is unclear if deep learning models for glaucoma
detection are population-generalizable, and few studies have been conducted to develop novel methods to
improve model population generalizability. We hypothesize that performance consistency across populations in
glaucoma detection can be improved by developing novel population-generalizable deep learning techniques.
We propose new generalizability-scaled performance metrics of the area under the receiver operating
characteristic curve, sensitivity, and specificity for population generalizability assessment, which penalize raw
performance metrics with performance variance across populations.
Overall Approach: Our models use optical coherence tomography scans and fundus photos to predict
glaucoma diagnosis defined by clinical guidelines. Our population-generalizable models will be compared with
standard models with and without oversampling and transfer learning measured by generalizability-scaled
performance metrics. Aims: (1) Assessing performance generalizability of existing deep learning models
and developing a population scaling approach. We will quantify the performance population generalizability
for the three widely used deep learning models including ResNet, EfficientNet, and Vision Transformer. We will
develop a novel population scaling approach to improve model generalizability by reweighting the training error
function based on the cross-population variance of training errors. (2) Developing population-conditioned
generative models for data augmentation to improve performance generalizability. We will develop
population-conditioned generative models to synthesize training data. The generated data will be used to
improve data availability across populations for training glaucoma detection models. (3) Developing
population normalization models to improve glaucoma detection generalizability. We will develop a
population normalization technique to balance feature importance across populations. We will integrate the
three population-generalizable approaches to maximize performance generalizability.
Main Deliverables and Impacts: Our population-generalizable deep learning models for automated glaucoma
screening will greatly benefit patients by providing more effective glaucoma screening. We will release a large
de-identified dataset of 10,000 patients to the public to study the population generalizability of medical artificial
intelligence.

Public health relevance
Project Narrative This project will develop population-generalizable deep learning models to improve performance consistency across populations in automated glaucoma detection, which will greatly benefit patients by providing more effective glaucoma screening. Our novel population-generalizable deep learning models can also be used in other disease screening tasks to generate a broader impact on various medical artificial intelligence applications. In addition to our technical innovations, we will curate, clean, de-identify, and release a large dataset of 10,000 patients to the public, including optical coherence tomography scans, fundus photos, glaucoma diagnostic data, and demographic information to enable a broader community of researchers to study the population generalizability of medical artificial intelligence.